PF4+ Monocyte-derived macrophages protect the blood brain barrier after stroke

Current stroke therapies aim to restore blood flow and protect the post-mitotic cells in the brain, but few existing
approaches influence the long-lasting immune responses that are responsible for tissue repair. In homeostasis,
the brain parenchyma is protected by the blood-brain barrier (BBB), which prevents the passage of large
molecules, pathogens, and leukocytes. Cellular distress unleashed by ischemia leads to BBB breakdown, which
exacerbates neuroinflammation and brain injury. Angiogenesis is an important regenerative process after stroke.
However, quick generation of new vessels without mature barrier function necessitates further BBB leakage, so
the timing of angiogenesis must be controlled to avoid vascular leakage and runaway inflammation.
Monocytes infiltrate the brain parenchyma early after stroke, which can cause harmful edema and worsen
outcomes in the short term. However, the recruitment of blood monocytes is also essential for stroke recovery,
as monocyte-derived macrophages (MDM) prevent hemorrhagic transformation and regulate angiogenesis and
wound repair in mouse models of cerebrovascular injury. Blocking MDM recruitment has been reported to
exacerbate behavioral deficits in stroke models.
Using scRNAseq, we identified a population of C-C chemokine receptor type 2 negative (CCR2-) MDM present
in the mouse brain 3 days after stroke. These cells express mRNA transcripts consistent with an anti-angiogenic,
immuno-suppressive phenotype. Platelet factor 4 (PF4) is specifically expressed in this population. Infiltrating
MDM express PF4Cre upon brain infiltration, allowing us to visualize PF4+ cells by their expression of tdTomato
(PF4-tdT). We used the PF4Cre mouse to specifically deplete PF4+ MDM. I will use this model to characterize
the phenotype and function of these cells after transient middle cerebral artery occlusion (tMCAO). I hypothesize
that PF4+CCR2- MDM preserve BBB integrity in the early stages of stroke recovery by limiting angiogenesis
and inflammation, and that specific cues from the CNS trigger monocyte differentiation into this state. Aim 1:
Confirm that PF4+CCR2- MDM produce antiangiogenic and immunosuppressive proteins that inhibit early
angiogenesis after stroke. I will prove that selective depletion of PF4+ MDM dysregulates angiogenesis after
stroke by comparing endothelial cell proliferation and by observing vessel growth in vivo using longitudinal two-
photon microscopy. Aim 2: Determine if PF4+ MDM promote BBB integrity after stroke. PF4+ MDM depletion
and adoptive cell transfer will be applied to interrogate their function in maintaining BBB integrity. I will observe
BBB permeability over the first week of tMCAO recovery in vivo using two-photon microscopy.

Public health relevance
Project Narrative_________________________________________________________________________ Ischemic stroke is a leading cause of long-term disability and results in the rapid recruitment of immune cells from outside of the brain to respond to distress signals from delicate brain cells. The proposed research will characterize a population of protective immune cells that control the process of blood vessel re-growth after stroke and prevent brain inflammation. The project will identify potential therapeutic strategies to improve blood vessel repair in the first week of stroke recovery by promoting protective functions in these brain-infiltrating immune cells.